Core D: Research Experience and Training Coordination Core

PROJECT SUMMARY/ABSTRACT – RESEARCH EXPERIENCE AND TRAINING COORDINATION CORE
N-Nitrosamines are a family of chemicals that include some of the most potent mutagens
known. N-Nitrosamines are a major concern for people who live near the Olin Chemical Superfund
Site, and they are also a concern of the Passamaquoddy Tribe, because the water treatment methods
used for their drinking water are known to lead to formation of N-nitrosamines. The mission of the
Research Experience and Training Coordination Core (RETCC) is to recruit, train, and engage the
best and the brightest students for careers in Biomedical Research (BMR) and Environmental Science
and Engineering (ESE) with a focus on public health. With support from the RETCC, trainees will
participate in all of the proposed research, engagement, and translation activities, and they will
contribute data to and beneﬁt from the Data Management and Analysis Core (DMAC). As such, trainees
fuel the entire MIT SRP program. By fostering and enabling interactions among trainees and between
trainees and leaders, the RETCC supports an innovative Systems Approach of inter-dependencies among
subsystems (Projects and Cores). Via a Systems Approach, all trainees impact and are impacted by
all of the Projects and Cores via a network of connections that are fostered by the Administrative
Core and the DMAC. Data generated by trainees will be managed by the Data Management and Analysis
Core and will be integrated with data from other parts of the program to contribute to risk
evaluation. Innovative aspects of the RETCC include cross- disciplinary research opportunities and
a new “MIT SRP Exploration Program” that enables trainees to spend time in other MIT laboratories.
In addition, there will be several approaches to support pipeline development so as to increase the
number of top students pursuing careers in environmental health sciences and engineering.

Speciﬁc Aim 1 is to provide opportunities to trainees for research, translation, community
engagement, and data analysis that will help protect human health from hazardous chemicals.

Speciﬁc Aim 2 is to strengthen and create programs to promote professional development.

Speciﬁc Aim 3 is to provide formal training to ensure that MIT SRP trainees have
successful careers in biomedical research and environmental science and engineering.
The Administrative Core will foster opportunities for trainees to participate in research
translation, which includes interactions with stakeholders. Furthermore, the Community Engagement
Core (CEC) will open doors for trainees to work with community members, including helping to deploy
sensors and a ﬁltration device that will destroy N- nitrosamines. Taken together, the RETCC
provides the foundation upon which trainees thrive and enables the collective impact of the entire program.

Public health relevance
PROJECT NARRATIVE – RESEARCH EXPERIENCE AND TRAINING COORDINATION CORE The Research Experience and Training Coordination Core (RETCC) recruits the best and the brightest trainees, provides cross disciplinary research training, and propels all of the activities of the MIT Superfund Research Program that, together, enable protection of people from the eﬀects of hazardous chemicals. The RETCC coordinates with the Administrative Core and the Community Engagement Core to ensure that trainees have exciting research translation opportunities (and regular contact with community members and organizations at the local, state, national, and tribal levels), as well as opportunities to listen to, learn from, and collaborate with community members and tribes. By fostering teamwork and nurturing trainees with a supportive environment, strong mentorship, and formal and informal enrichment activities, the MIT SRP trainees will continue to promote the public health impact of the MIT SRP.